MHC Genetic Typing

PROJECT SUMMARY/ABSTRACT:
This specific Core will maintain a genetically diverse SPF rhesus macaque colony of Indian origin for use in AIDS-
related and other infectious or autoimmune disease-related research that requires data on the MHC class I or II
genetics. We have designed genetic management strategies for the CPRC SPF and conventional colonies since
2015 in order to efficiently monitor the genetic diversity of SPF animals. As a result, we have constructed
multigenerational pedigrees for the CPRC SPF program. We will use this relational database to aid researchers
in selecting appropriate animals for their specific needs, maintaining genetic diversity in the colony, and
enhancing the production of new SPF animals during the proposed project. Our genetic management plan aims
to minimize inbreeding and genetic subdivisions and retain diversity essential for sustaining the supply of NHP
for biomedical research. We will continue using STR-based parentage confirmation, pedigree construction, and
information on MHC class I, class II DRB, class II DQA/B, and class II DPA/B loci to manage the CPRC's SPF
rhesus macaques genetically. We have successfully integrated information on class I and II MHC data obtained
through the Illumina MiSeq deep sequencing methods into the colony's genetic database. The specific aim of the
MHC Typing Core is: To continue the comprehensive genetic management of the SPF colony including an
expanded MHC haplotyping program.

Public health relevance
NARRATIVE: We have designed genetic management strategies for the CPRC SPF and conventional colonies since 2015 in order to efficiently monitor the genetic diversity of SPF animals. As a result, we have constructed multigenerational pedigrees for the CPRC SPF program. We will use this relational database to aid researchers in selecting appropriate animals for their specific needs, maintaining genetic diversity in the colony, and enhancing the production of new SPF animals during the proposed project.